Pharmaceutical Sciences and Pharmacogenomics

PROJECT SUMMARY
The Pharmaceutical Sciences and Pharmacogenomics (PSPG) Graduate Program is a unique, dynamic,
contemporary program in pharmaceutical sciences and pharmacogenomics at the University of California San
Francisco that attracts diverse faculty and students who share a common interest in applying basic sciences to
challenging research topics in drug development and precision drug therapy. The graduate program reflects
exciting scientific developments in the area of genomics, quantitative and systems pharmacology, therapeutics
and computation that have far-reaching implications to the pharmaceutical and pharmacological sciences. The
goal of the PSPG graduate program is to educate and train Ph.D. students to conceptualize, design and execute
innovative scientific research in the interdisciplinary scientific areas encompassed by modern pharmaceutical
sciences. The program brings together 66 well-funded faculty members spanning 17 departments. This
multidisciplinary and unique graduate program has a dual focus: 1) pharmaceutical sciences and drug
development, including molecular and systems pharmacology, drug delivery and therapeutic bioengineering,
gene therapy and pharmacokinetics/pharmacodynamics and modeling; and 2) pharmacogenomics, the
application of genetics and genomics for the development of novel therapeutics and the optimal use of drugs in
individual patients for precision medicine. The training program includes a series of core courses providing an
in-depth understanding of the principles of pharmaceutical sciences and pharmacogenomics, including an
innovative new core course in systems pharmacology. Core courses are complemented by electives covering
advanced drug delivery and pharmacokinetic principles, principles of genetics and cell biology, bioinformatics,
tissue and organ biology, CRISPR therapeutics and computer programming. Students also participate in
laboratory rotations that expose them to the diversity of potential projects available for their dissertation research
and a university-wide course on responsible conduct of research. The program immerses trainees in the culture
of science through a journal club with students across four basic science graduate programs that are focused
on quantitative approaches to studying biology, a seminar program which brings in leading academic, regulatory
and industrial scientists, student research presentations, and an annual retreat. The program goal is to recruit 8-
12 outstanding Ph.D. students per year, plus at least one student for a combined Pharm.D./Ph.D. degree.
Underrepresented minority students are actively recruited through a number of faculty activities and represent
20% of our students. Upon graduation, the new PSPG Ph.D. scientist will have the ethics, knowledge and tools
necessary to become independent researchers, and also the passion and enthusiasm to make impactful
contributions to the pharmaceutical sciences and pharmacogenomics field throughout their career.

Public health relevance
PROJECT NARRATIVE There is an increasing need for the development of new and effective drug therapies for the treatment of disease that can be tailored for individual patients. Students in the Pharmaceutical Sciences and Pharmacogenomics Graduate Program are trained to be future scientific leaders in this area. Their training will prepare them to develop effective treatment strategies for existing and newly developed drugs that consider the principles of pharmacology and our advancing knowledge of personal genetics.